Variation in chemotactic strategies within and across bacterial species

Abstract
Bacteria use a conserved signaling pathway to direct their behavior in chemical gradients. This directed motion,
called chemotaxis, is essential for clinically relevant phenomena like biofilm formation and host invasion.
Extensive work has characterized the dynamics of chemical sensing, adaptation, and behavior in Escherichia
coli. However, a fully integrated picture of chemotaxis is currently lacking in other bacteria. Given the diversity of
sensing and behavioral strategies across bacteria, to fully understand the role of chemotaxis in pathogenicity, it
is essential to characterize the interaction between signal transduction and behavior in other species.
In this application, the PI proposes to extend two experimental lines of inquiry first explored in E. coli, to
pathogenic bacteria. One direction of the lab is to use single-cell fluorescence resonance energy transfer to
characterize the dynamics of chemotactic signal processing to Vibrio cholerae. While E. coli navigate with ‘run-
and-tumble’ cycles, alternating between straight ‘runs’, and stationary reorienting ‘tumbles’, V. cholerae and other
singly-flagellated bacteria navigate with ‘run-reverse-flick’ cycles, where after a run, cells backtrack along their
run trajectory, and then ‘flick’ at a 90o angle. In a chemical gradient, different swimming behaviors will generate
inputs to the chemosensory system with different statistics. Characterizing chemosensory responses in V.
cholerae will reveal how a common signaling architecture can be repurposed to process diverse signals and
control diverse chemotaxis strategies.
Another direction of the lab is to study the role of cell-to-cell variability in chemotactic behavior and its effect on
the collective migration of populations. By consuming environmental attractants, groups of bacteria can establish
moving attractant gradients to follow, which results into waves or bands of migrating bacteria that can travel over
long distances. For E. coli, our lab previously demonstrated that during collective migration individual phenotypes
spontaneously sort themselves along the traveling gradient according to their chemotactic performance.
Importantly, we found that the leader-follower organization that emerges enables traveling populations to, over
time, adapt their phenotypic composition to the environments they traverse by culling the weakest phenotypes
that end up at the back of the traveling group. Moving forward, we want to understand the dynamics of how new
spatial configurations of chemotaxis phenotypes emerge when populations encounter new environments, and
the consequences of spatial sorting in migrating populations on pathogenicity. As such, we will examine
phenotypic diversity in traveling waves of E. coli migrating through interfaces between liquid and agar, and of
Pseudomonas aeruginosa were virulence traits and chemotaxis are often coregulated.

Public health relevance
Project Narrative Chemotaxis is controlled by a conserved signaling architecture and nearly half of all human pathogenic bacteria possess genes encoding one or more of these chemosensory signaling pathways. Yet, a quantitative understanding of how these systems dynamically process signals and reconciliate phenotypic diversity with collective behavior has, so far, only been available in Escherichia coli. This project will apply the tools and expertise developed studying E. coli chemotaxis to the analysis of chemosensory signal transduction and collective migration in two pathogens, V. cholerae and P. aeruginosa, paving the way for a quantitative and predictive understanding for the role of chemotaxis in infection.